Pediatric Critical Care Research Network at Children's Hospital of Philadelphia

? DESCRIPTION (provided by applicant): Pediatric Critical Care Medicine has developed as a clinical art based on extrapolated data from adult and animal studies. The Eunice Kennedy Shriver National Institute of Child Health and Human Development (NICHD) has developed a Collaborative Pediatric Critical Care Research Network (CPCCRN) to transform Pediatric Critical Care from a pathophysiology based art to an evidence based scientific practice through innovative, cutting-edge, multi-disciplinary clinical investigations. The Children's Hospital of Philadelphia (CHOP) has been an outstanding CPCCRN Clinical Site from 2009-2014, led by Drs. Berg and Zipper. This proposal for CHOP to continue to be a CPCCRN site has three components: #1: To demonstrate CHOP's ability to be an outstanding CPCCRN Clinical Site. CHOP is a top ranked children's hospital with one of the largest pediatric research programs in the country: >$138 million/year in total federal awards and an annual budget >$329 million. CHOP has the nation's largest pediatric health care system, and is one of the nation's largest children's hospitals with >500 beds. CHOP's Critical Care Medicine Program is one of the largest in the nation with 55 PICU beds, 32 CICU beds, and 4200 admissions/year, providing a large and diverse patient base for clinical research. CHOP Critical Care Medicine has 9 investigators with =20% salary support from federal research funding, >180 peer-reviewed research publications in the last 3 years, and nationally recognized pediatric critical care clinicl research programs. #2: To demonstrate that CHOP has been an outstanding CPCCRN Clinical Site (2009-2014). From 2009-2014, CHOP has been the leading enrollment site for CPCCRN studies. Dr. Berg has led four CPCCRN CPR studies; Dr. Zipper has led two CPCCRN pharmacology studies; and Ms. Dilbert (CHOP CPCCRN Research Coordinator) has led a CPCCRN research coordinator education and management program. Specific Aim 3: To present a transformative research concept proposal that highlights our capabilities and strengths for development and design of high-impact cooperative protocols in the network: a life-saving approach to improve survival among children who need cardiopulmonary resuscitation (CPR). The Children's Hospital of Philadelphia is an ideal Clinical Site for CPCCRN, based on: 1) the outstanding resources, institutional commitment, programs, faculty, productivity, and future opportunities; 2) CHOP's performance as an outstanding CPCCRN Clinical Site from 2009-2014; and 3) the exciting concept proposal demonstrating our abilities to be CPCCRN leaders.

Public health relevance
PUBLIC HEALTH RELEVANCE: Much of the technology and many therapies in pediatric critical care have evolved without adequate study; therefore the risks and benefits of intensive care practices remain largely unknown. Collaborative research is needed in order to make good decisions regarding effective critical care practices. The Children's Hospital of Philadelphia (CHOP) Critical Care Medicine program is an ideal Collaborative Pediatric Critical Care Research Network (CPCCRN) Clinical Site as CHOP is a large, diverse, multi-disciplinary, research intense, premiere pediatric academic health center.